Center for Team Effectiveness to Accelerate EBP Implementation in Children's Mental Health Services: Admin Core

PROJECT SUMMARY (Administrative Core)
The TEAMS Center Administrative Core will serve as the essential hub for Center activities and team
members (including investigators, community partners, and trainees). This Core will provide the organizational
leadership and infrastructure to create and maintain a well-functioning center and will be charged with
coordinating the community-engaged scientific, administrative, and governance activities of the Center. It will
operate through three functional units or teams (Center and Research Operations, Community-Engaged
Research, and Training and Dissemination). The Administrative Core team brings substantive expertise in
children’s mental health effectiveness and implementation trials, evidence-based practices (EBPs) for common
children’s mental health conditions, and community academic partnership models. The Administrative Core will
apply the Center’s Team Effectiveness for Implementation Science Model to build team processes to promote
team effectiveness (i.e. a well-functioning and productive Center). The Center and Research Operations team
will coordinate the Center’s activities to optimize efficiencies and promote research progress. The Community-
Engaged Research team will facilitate the application of team effectiveness research to optimize EBP
implementation practice in key public service systems caring for children with mental health concerns. This team
will convene four “system” workgroups to advise projects, identify relevant team mechanisms and team
development interventions to promote EBP implementation in each service system (specialty mental health,
schools, pediatric healthcare, child welfare services), and priority research questions within and across systems.
It will also launch new community-partnered research through R03 pilot studies. The Training and Dissemination
team will provide training in children’s mental health team-based implementation research and practice and
broadly disseminate Center innovations. It will provide interdisciplinary and mentored training to internal Center
trainees and disseminate Center resources and trainings to national and global networks.